CHIMERIC CELL-SURFACE CYTOKINE FOR TUMOR VACCINES

DESCRIPTION: (Adapted from the applicant's abstract) A number of strategies are under development by various groups for the creation of therapeutic tumor vaccines using gene transfer into autologous tumor cells. However, gene transfer entails a number of technical problems that limit both the clinical utility and commercial viability of such vaccines. As an alternative, this project will generate a prototype GPA-linked molecule that improves the efficiency of events in the afferent limb of the immune response. The utility of this molecule in the creation of tumor vaccines will be tested in mouse models. PROPOSED COMMERCIAL APPLICATION: NOT AVAILABLE